A Patient Oriented Research Program for Surgical Oncologists

DESCRIPTION (provided by applicant): This K24 award is being sought to support the efforts of the principal investigator, Dr. James Goydos, as he builds his clinical and translational research program. He is the Director of the Melanoma and Soft Tissue Oncology Program at the Robert Wood Johnson Medical School and The Cancer Institute of New Jersey. He is the sole funded clinical researcher in the Department of Surgery at our Institution and he carries a large clinical burden in support of our large Melanoma Program. A K24 award will allow our Institution to hire a new junior Surgical Oncologist to join Dr. Goydos' program to relieve much of his clinical duties so that he can concentrate on Patient Oriented Research and mentoring our junior faculty. Dr. Goydos has a robust clinical research program that is translating the findings in our basic science laboratories into clinical practice. He has just completed accrual to a phase 0 trial of the glutamate signaling pathway inhibiting compound Riluzole in patients with resectable stage III and IV melanoma and the results are very encouraging. Dr. Goydos plans to expand this research with a phase II trial of Riluzole in patients with stage IV melanoma and he is planning future trials with combination therapies and in the adjuvant setting. Dr. Goydos will be supporting his research with an ongoing R21 Quick Trial that supports the phase II trial. He is also developing a R01 level clinical project that will be part of a P01 application that is scheduled for submission in the Winter of 2009. Dr. Goydos currently acts as the primary mentor for one junior faculty member in the Division of Surgical Oncology (Dr. Jonathan Lee) and will be taking on three other junior faculty members as mentees if he obtains this award. He will also be involved in developing a clinical and translational research curriculum for the Department of Surgery.

Public health relevance
Project Narrative There are not enough Surgeons trained in art and science of patient oriented research so we must encourage those Surgeons with the skills need to mentor the next generation of Surgical Researchers to apply the time and resources needed for this endeavor. To do this we must free Reseachers from the day to day clinical duties that take up so much of our time This award will help us accomplish these goals. __SpecificAimsTextDelimiter__ Section 1: Currently Supported Research A: Hypotheses and Specific Aims: Recently, our group described a heretofore-unknown component of melanoma pathogenesis. A transgenic murine model of melanoma was developed by the ectopic expression of metabotropic glutamate receptor (Grm) 1 in melanocytes9. These mice spontaneously develop melanocytic lesions indistinguishable from human melanoma. When we examined a bank of human melanoma specimens we found that 80% ectopically expressed this protein and this expression was found in primary lesions, regional metastatic lesions, and distant metastases but not in normal skin or melanocytes from the same patients. Furthermore, when we activated this receptor in a melanoma cell line using a specific Grm1 agonist we found upregulation of the phosphorylated form of ERK, demonstrating activation of the MAPK pathway upon activation of this receptor7, 14. Because the MAPK pathway has been shown to be important in the pathogenesis of melanoma12, 15 we hypothesized that one of the ways that ectopic expression of Grm1 leads to the development of melanoma is through the activation of this pathway. Importantly, blocking the first two components of this pathway with B-Raf and N-Ras inhibitors would not affect Grm1 activation of downstream ERK because the Grm1 pathway appears to interact with the MAPK pathway through the activation of MEK by phosphokinase C. Grm1 activation in melanoma may act as a way to bypass N-Ras and B-Raf blockade while blocking Grm1, alone or in combination with N-Ras or B-Raf blockade, may prove of therapeutic benefit in patients with melanoma. To begin to test this hypothesis we conducted a phase 0 clinical trial using a well-studied glutamate-blocking agent in patients with resectable stage III and stage IV melanoma. The specific aims of this trial were: 1. Perform a Phase 0 Trial of Riluzole in Patients with Resectable Stage III and IV Melanoma 2. Examine pre and post-treatment tumor biopsy samples from our Phase 0 trial to determine the affects of Riluzole therapy on pathways important in melanoma pathogenesis.